PILOT PROJECTS

TBD

Public health relevance
We anticipate that our efforts will aid in the development of improved diagnostics and prognostic criteria for breast cancer, will assist in the stratification of patients for targeted aggressive treatments/therapies aimed at reducing tur:nor metastasis, and will permit the identification of high-risk populations and improve prevention strategies.